PATIENT OUTCOMES RELATED TO USE OF BLOOD PRODUCTS

This CDMAS project is comparing the difference in rates of infection, hematocrit levels, etc. for patients who received blood products and those who did not postoperatively.